NCI Research Specialist/Clinician Scientist Award for Urologic Oncology Research

Project Summary
As a urologic oncologist, most of my peers have focused on operating as much as possible
with the hope their efforts could positively effect change on an individual level. During my NCI
Urologic Oncology Fellowship, I was drawn to the power of clinical discovery working alongside
clinical investigators. A surgeon has limited research paths to create paradigm shifts in the field
beyond the operating room, as industry often ignores many of the critical questions facing us.
Fortunately, the NIH Cooperative Group network trials provide an avenue for clinical scientists to
impact the field by interacting with likeminded individuals, patient advocates, translational
researchers, statisticians, and operational staff. By early engagement in SWOG, I have been
afforded the opportunity to participate and lead several clinical trials before taking larger roles in
translational research initiatives. This cemented my passion as a clinician scientist hoping to lead
new initiatives in kidney cancer. I am fortunate to have assumed Co-Chair responsibilities within
SWOG’s Renal Subcommittee and the NCI Renal Task Force. These leadership roles allow me to
imprint the next generation of clinical trials. This also includes my involvement with a small renal
mass trial aimed at reducing overtreatment, that was developed through a Clinical Trials Planning
Meeting by much of the Renal Task Force and has been prioritized within SWOG this year with
plans for GU Steering Committee review later this year. Despite receiving academic and leadership
recognition, my engagement in NCI clinical research throughtrial participation, administrative
efforts, mentorship of SWOG investigators, protocol development, and travel for bi-annual
meetings, there is limited institutional support at UCLA for these endeavors. Similarly, the NCI
sponsored trials have resulted in a financial burden to staff and this investigator, as compared to
industry trials. Participation has largely been a result of my passion to provide patients an
opportunity for improved care. The R50 Research Specialist Award mechanism recognizes the
critical role that individuals can play to advance clinical science and can significantly advance my
work. In particular, the financial support associated with this Award will further my engagement
in available NIH protocols, provide time for protocol development including our new Small Renal
Mass Concept, provide the means to travel to SWOG and Renal Task force meetings, and allow
designated protected time that SWOG and Renal Task Force leadership requires. This Award
would be instrumental in my academic career development during a time where the is increasing
pressure to produce clinically. I am thrilled for this opportunity and appreciate UCLA recognizing
my efforts with this nomination.

Public health relevance
Project Narrative Dr. Brian Shuch directs the UCLA Kidney Cancer program, part of the Institute of Urologic Oncology’s multidisciplinary clinical and research program. He is an established leader in clinical and translational kidney cancer research including roles within the SWOG and NCI Renal Task Force. Having the R50 Award would provide dedicated support for 1) the significant research time allocated to the conduct of NCI trials, 2) the leadership commitments in SWOG and the Renal Task Force, 3) the pursuit of new clinical concepts including a recently prioritized protocol, and 4) to further engage UCLA investigators to become involved in NCI clinical research.